Predicting the spread of antimalarial drug resistance using deep learning surrogates

ABSTRACT
Malaria represents a major global public health challenge, killing 619,000 people each year,
predominantly children in Africa. The recent emergence of artemisinin partial resistance (ArtR)
in Africa has the potential to lead to a global public health crisis and may result in the failure of
test-and-treat strategies that serve as a cornerstone of malaria control. If it follows the historical
example of Southeast Asia, where ArtR parasites are now widespread, millions of additional
malaria cases could occur each year. A major challenge for disease ecology is understanding
and predicting how resistance to interventions emerges and spreads. For malaria, transmission
models in popular use today are simulation based, allowing for rich representations of
transmission cycles and also capturing the true random nature of infection. This creates
significant problems for model-based inference. Traditional inference methods like Bayesian
Markov chain Monte Carlo (MCMC) cannot be used in most cases, and more advanced
methods are limited in scope or power. Deep learning offers a new and general-purpose solution
to this problem. Deep neural networks (DNNs) trained on large amounts of simulation output
can learn the complex relationships between parameter inputs and outputs. The trained
“surrogate” model can then be used to produce outputs that closely resemble the original
simulation model in a fraction of the run-time, or they can be used within traditional Bayesian
MCMC to estimate parameters. This approach, referred to as “deep learning surrogates” (DLS),
is gaining traction in many areas of research but has not yet penetrated infectious disease
modeling. Most applications of DLS have focused on speeding up prediction. While this is an
important use-case, in infectious disease modeling we are equally interested in learning from
observed data. Here, mathematical models can provide estimates of crucial parameters like the
basic reproductive number of a pathogen, or more detailed outputs like the complete surface of
disease prevalence over a geographical region. Thus, DLS has enormous potential by linking
complex simulation models to traditional parameter estimation methods. The goal of the
proposal is to apply DLS methods to the urgent problem of antimalarial resistance in
Sub-Saharan Africa. Specifically we will: 1) develop a temporal DLS model to predict the
impact of drug policy interventions in Kinshasa Province, DRC and 2) develop spatial DLS
models to predict the spread of artemisinin resistance in the Great Lake region of Africa and
Ethiopia. In both cases, we will leverage some of the most comprehensive epidemiological and
genetic datasets available.

Public health relevance
PROJECT NARRATIVE Malaria remains one of the major global public health challenges and emerging resistance to antimalarials in Africa threaten to increase morbidity and mortality. Currently, a major challenge for disease ecology is understanding and predicting how resistance to interventions emerges and spreads, which is information that national control programs could use to tailor interventions. Here we use deep learning surrogates (DLS) to overcome current limitations in modeling approaches to develop surrogates to predict temporal and spatial emergence and spread of antimalarial resistance.